Workshop Series to Identify, Discuss and Develop Recommendations for the Optimal Generation and Use of In Vitro Assay Data for Tobacco Product Regulation

Project Summary/Abstract The Center for Tobacco Products (CTP) toxicity research priorities include “toxicological assays (in vivo and in vitro) to compare toxicity across different types of tobacco products within the same class, including electronic nicotine delivery systems (ENDS), cigars, waterpipes, and smokeless tobacco.” CTP regulatory guidance documents include genotoxicity in the types of toxicity information required for submissions. However, there are no standardized guidances and regulatory approved methods for the application of traditional genetic toxicology assays to evaluate and compare toxicities of various tobacco products, including ENDS. Therefore, the Institute for In Vitro Sciences (IIVS), a 501(c)(3) nonprofit organization, has organized a Workshop Series to identify, discuss and develop recommendations for the best scientific/technical approaches for generating and interpreting in vitro assay data for comparing toxicity within and across tobacco product classes. Designed as true working meetings, invited expert stakeholders will draw on their collective experiences to discuss and to develop recommendations that will be published. Although the initial focus will be on the regulatory genetic toxicology assays (Ames test, in vitro mammalian assays for cytogenetic damage and gene mutation), much of the information discussed will be applicable to all in vitro assays. These workshops will provide a unique opportunity for multiple stakeholders to share their expertise in developing recommendations that will serve as a resource for regulatory agencies, academic laboratories, and industry as they address the public health issues related to the use of tobacco products. It is envisioned that some of these recommendations would form the basis for formal guidance documents and/or serve as authoritative publications that can be referenced for optimal methodologies and data interpretation. The first workshop in this series (November 2018) identified important issues for using in vitro genetic toxicology assays for evaluating tobacco products. This list provides the focused high-priority topics for subsequent workshops. Sub-workgroups were established to collect background information for generating appropriate tobacco test samples, and these reports were presented and discussed during the second workshop (June 2019). During the third and fourth workshops (scheduled for February and September 2020) the workgroup will tackle key challenges and develop consensus recommendations. Topics will include: (1) the relative merits and representativeness, of different types of samples and the identification of critical factors, pitfalls, and recommendations for using each sample type (with an emphasis on whole smoke and aerosols) for in vitro testing, (2) reference samples, (3) appropriate chemical characterization of samples, (4) appropriate Ames test strains, (5) considerations for using different mammalian cell lines and potential new strategies for exposing suspension cells to whole smoke/aerosol, (6) recommendations for top sample concentration, and (7) approaches to determining actual target exposure.

Public health relevance
Project Narrative Building upon two successful workshops addressing in vitro COPD models and in vitro exposure systems, IIVS is organizing and hosting a series of expert Workshops to identify, discuss and publish recommendations for the best scientific/technical approaches to the generation and interpretation of in vitro assay (generally genetic toxicity) data that can be used to compare toxicity across different products within and between classes of tobacco products. These recommendations will assist public health researchers in performing high quality experiments to understand the relative toxicities of conventional cigarettes, the new Electronic Nicotine Delivery Systems (ENDS), and other tobacco-related products. These studies will then provide public health officials with the high quality data they need to make science-based decisions during the regulation of tobacco related products.